Neutral Sphingomyelinases and Bioactive Ceramides

Abstract
The overall goals of this research proposal are to define specific pathways of sphingolipid metabolism,
define specific roles, define mechanisms, and help place the field of bioactive lipids on solid mechanistic
grounds. Based on strong ongoing data, we propose the overall hypothesis that individual enzymes of
ceramide metabolism serve as transducers of specific inputs, and the product bioactive sphingolipids function
to mediate key responses. This proposal will develop this paradigm in the case of the DNA damage response
and other stimuli activating mammalian and yeast neutral sphingomyelinases in distinct compartments leading
to formation of compartmentalized and species-specific ceramides. We propose the following major goals: 1.
Advance our understanding of structure and activation of nSMase2; 2. Develop tools and approaches
to probe compartment-specific functions of bioactive sphingolipids and neutral sphingomyelinases; 3.
Define functions and mechanisms of neutral sphingomyelinases in the nucleus, especially in the DNA
Damage Response; and 4. Define mechanisms of regulation of protein phosphatases by ceramides. Taken
together, we endeavor to advance our understanding of bioactive sphingolipids and reduce the complexities of
the field to manageable and specific components that promise to shed important light on how these specific
pathways function, and their specific roles in stress responses. The ongoing results are defining totally
unexpected roles for neutral sphingomyelinases in distinct compartments, including the eukaryotic DNA
damage response through a nuclear lipid-mediated pathway. These are critical towards the understanding of
human disease (cancer) and therapeutics.

Public health relevance
Sphingolipids are a class of fatty molecules that have been thought to serve primarily as structural molecules in formation of cell membranes. Our work identified specific functions for individual sphingolipids, thus leading to their appreciation as `bioactive molecules', and in this proposal we focus on key enzymes of sphingolipid metabolism with important functions in cell stress responses. In the process of defining these pathways and mechanisms, we tackle some of the most recalcitrant problems in understanding these pathways, and we provide the foundations that allow many investigators to probe the health and therapeutic significance of the enzymes and pathways we are defining.